Evolution of T cell immunity in blood and tissues over childhood

PROJECT SUMMARY
Immune system development during infancy and childhood sets the stage for a lifetime of protective immunity.
Infants and children are known to be more susceptible to ubiquitous respiratory and mucosal pathogens for
which adults have prior exposures. However, our recent experience in the COVID-19 pandemic, in which
children were markedly less susceptible than adults to disease from infection with the novel respiratory virus
SARS-CoV-2, indicate that children's immune systems can be highly effective to newly encountered
pathogens. The diverse repertoire of naïve T cells, their ability to differentiate to tissue homing effector cells,
which mediate pathogen clearance at infection sites, and the subsequent generation of long-lived memory T
cells are critical events in immune responses that are not defined in children. Identifying the mechanisms by
which T cells respond to antigenic challenges and establish immunological memory throughout infancy and
childhood are essential for improving vaccines and immunotherapies to protect the next generation. My
laboratory has been studying early life immunity in mouse models and novel human samples, including tissues
from infant and pediatric organ donors, with a focus on how protective tissue resident memory T cells (TRM)
become established in early life and mature over childhood. We pioneered the study of human tissue immunity
in organ donor tissues, identifying that the majority of T cells across tissues in the body are TRM, which begin
to form in early life in intestines and mature over age. We have identified fundamental and intrinsic differences
in infant compared to adult T cells at the earliest stages in T cell activation and have investigated anti-viral
immunity to SARS-CoV-2 in different pediatric cohorts. Our central hypothesis is that pediatric T cell responses
are distinct due to intrinsic signaling mechanisms, the specific tissue environment, and the antigenic exposure
history. In this study, we will build on our results, human samples, and cohorts to elucidate mechanisms for the
distinct responses of pediatric T cells and their differentiation fate, maturation in tissues, and evolving response
to vaccines. In aim 1, we will identify mechanisms for the distinct activation of pediatric naïve T cells, including
how early events during T cell conjugate formation and cell division impact cell fate in early life and childhood
for mouse and human T cells. In aim 2, we will elucidate TRM differentiation pathways and the role of the
tissue in TRM maturation by high dimensional single cell profiling of human TRM in intestines and lungs across
all ages of childhood, and use mouse models to address the role of persistence and tissue environment in
TRM maturation. In aim 3, we will analyze vaccine-specific immune responses and evolution over childhood in
established cohorts of children who previously had different clinical manifestations of SARS-CoV-2 infection, or
were not infected. We will assess virus-specific T cell and antibody responses to the current COVID mRNA
vaccines over time and age. Together, the proposed studies will comprehensively define immune system
maturation over this critical and formative window of childhood.

Public health relevance
PROJECT NARRATIVE Immune responses in children are known to be distinct, setting the stage for a lifetime of health or disease. This proposal is designed to explore the hypothesis that pediatric T cell responses are shaped by factors inherent to the cell, its tissue environment, and the individual's infection history. The knowledge gained by this study will provide novel insights into early life immune development which will improve our ability to prevent and treat childhood and lifelong diseases.